A Center for the Convergence of Physical Science and Cancer Biology

DESCRIPTION (provided by applicant): The Administrative Unit will act to support and coordinate project administration and operation within the Center. A Physical Science Leader (Dr. Lindsay) and a Life Science Leader (Dr. Grady) and a project management team (a program manager and two coordinators) will support the Project Director (Dr. Davies). The project management team will oversee operational details of the Center. The Center Advisory Committee will provide the strategic guidance for the Center, incorporating information generated through the Cancer Forum (Core 1), as well as be responsible for supporting all significant Center activities such as drafting the Pilot Project opportunity announcements. The Project Director (Dr. Davies) and Senior Co-investigator (Dr. Grady) will participate as members of the Physical Sciences Oncology Center Network Steering Committee. A pragmatic organizational structure and comprehensive communication plan will ensure cooperative, effective, and congruent collaboration between Projects, Cores, and units within the Center and the Network of PS-OCs. The Unit provides a detailed schedule for all required meetings, including identifying meeting organizers, required attendees, and purpose of the meeting. The Unit also provides specific guidance regarding Center deliverables, such as website content, regular reports, and Pilot Project announcements.